Pathogenic Role of Malondialdehyde-Acetaldehyde Adducts in Rheumatoid Arthritis

It has been estimated that rheumatologist-diagnosed Rheumatoid arthritis (RA) is seen in up to 2% of the
users of VA healthcare. Moreover, compared to RA in women, RA in men (the primary VA demographic)
leads to greater morbidity, a higher frequency of extra-articular manifestations, and worse disease-related
outcomes. With an aging and predominantly male veteran population, it is anticipated that the burden posed by
RA will grow dramatically in the VA in coming years. This is highly relevant given the association of RA with;
substantially higher mortality risk among veterans, in addition to high rates of work-related disability, and annual
societal costs approaching $40 billion in the US alone. Over the past few years, there have been substantial
advances in our understanding of RA pathogenesis. Anti-citrullinated protein antibody (ACPA) is highly specific
to RA with recent studies suggesting that ACPA are pathogenic with seropositivity portending a poor
prognosis including more rapid joint destruction. However, the mechanism(s) by which citrullinated proteins/
peptides are recognized and processed and presented in the context of co-stimulatory molecules is still not
well understood. Studies have shown that a unique post-translational modification of proteins that
occurs under oxidative stress by malondialdehyde (MDA) and acetaldehyde (AA), termed MAA, up-
regulates MHC Class II, increases co-stimulatory molecules and generates cytotoxic and pro-inflammatory
responses in the absence of exogenous adjuvant. For the first time, our group has shown that MAA modified
proteins are detected in synovial tissues of RA patients and co-localize with citrullinated antigen. Additionally,
anti-MAA antibody isotypes are independently associated with ACPA concentration (p < 0.0001) in patients
with established RA. Therefore, our overarching hypothesis is that these two post-translational
modifications (MAA modification and citrullination) act in concert to drive tolerance loss resulting in
the anti-citrulline autoimmune responses characteristic of RA. To investigate this hypothesis, studies in
Aim 1 will evaluate adaptive immune responses (autoantibody and T cell responses) to citrullinated and/or
MAA-modified proteins. We anticipate that compared to antigens that are only citrullinated or only MAA
modified, immune responses to co-modified proteins will be higher in mice following immunization and in RA
patients. As prior data has demonstrated that SRs mediate the biological effects of MAA-modified proteins
on APCs and other cells, Aim 2 is designed to identify the specific SRs that mediate the effects of
citrullinated and/or MAA-modified proteins in RA. In Sub-Aim #1, studies will leverage Chinese Hamster
Ovary (CHO) cell lines that are already available in our laboratory and that have been transfected with
each of the various SRs. Results of initial experiments will inform the design of subsequent binding studies
using human APCs (that simultaneously express multiple SRs) and cell types unique to synovial tissue. Using
available SR inhibitors alone or in combination will aid in defining which receptors are found on each cell
type. In Sub-Aim #2, will focus on the biological effects (fibrosis, inflammation, calcium influx, PAD
expression and citrullination) of the binding of MAA modified and/or citrullinated proteins to the different cell
types. Thus, the innovative aspect of this proposal is its focus on the melding of two naturally occurring biological
events (citrullination and oxidative stress) that conspire to initiate highly specific autoimmune responses,
promoting the development and progression of RA.

Public health relevance
Rheumatoid arthritis (RA) is a systemic autoimmune disease estimated to affect up to 2% of all VA healthcare users, highly relevant since male veterans with RA experience more than twice the mortality as age- matched men from the general population. We have recently shown that malondialdehyde-acetaldehyde adducts (MAA), formed during inflammation and resulting oxidative stress, are expressed in RA joint tissues and immune responses to MAA are robustly associated with autoantibodies that are nearly exclusive to RA. Proposed research efforts will focus on identifying the immunologic mechanisms linking MAA adduct formation with the development and progression of RA and will identify novel biomarkers that could be used for diagnosis and predicting future disease. Importantly, results from this work will lead to an improved understanding factors leading to RA development and will provide insight into new approaches in treatment and prevention.